Biostatistics Core

Core 2 Biostatisics Project Summary/Abstract
The purpose of Core 2 Biostatistics is to provide statistical support to the four Projects as well as to the
initiatives involving clinical studies through Core 3 and statistical assessment of biospecimens through Core 1,
all toward the goal of development of curative options for patients with AML, MDS, and CMML. This Core
assures that the design, conduct, and analyses of all experiments—clinical, correlative, animal, or basic science-
-use robust statistical techniques that are appropriately implemented. This central resource thereby helps to
elucidate the mechanisms as well as the vulnerabilities of myeloid malignancies.

Public health relevance
PROJECT NARRATIVE - Core 2 Biostatistics The goal of Core 2 Biostatistics is to assure that all experiments conducted through this P01 in in myeloid malignancies have access to state-of-the-art statistical support for their design and analysis. This extends to the basic science and murine experiments described in the four Projects, as well as to the clinical and correlative studies undertaken in conjunction with the Clinical Core (Core 3) and the Biospecimen Core (Core 1). This assures that the work performed on this P01 will be robust and reproducible, and thereby contribute to an improved understanding of these diseases.